Montagna Symposium on the Biology of Skin

PROJECT SUMMARY
The Montagna Symposium on the Biology of Skin has gathered nearly annually for 70 years with the goal of
bringing together leading scientists and clinical investigators in a uniquely designed conference to drive forward
the field of skin biology. Through cutting edge presentations and lively conversations in a laid back atmosphere
near Portland, Oregon, the conference serves and aims to: 1) Discuss new findings, techniques, and goals in
skin biology and adjacent fields; 2) Foster cross-disciplinary and innovative collaborations among disciplines that
will enrich the scientific and clinical specialty and bring novel solutions to bear on skin diseases; and 3)
Encourage young investigators to dream, imagine, and grow into the next generation of leading scientists and
dermatologists who can drive the field forward. Each year the Symposium addresses a different topic in skin
biology research and unanswered questions about causes and cures for skin diseases. Discoveries made in the
skin have enriched knowledge and treatment options in other organ systems for decades, as skin is the most
visible organ in the human body, presenting ample opportunities for its study. The unique atmosphere and limited
number of participants provides opportunity to debate controversies, propose solutions to puzzles and strategies
to overcome roadblocks, set new research agendas, and grasp opportunities for translation to new treatments.
Interactions are 1) Among participants in basic research, translational, clinical, patient care, disease-focused
foundation-led, and pharmaceutical researchers; 2) Between trainees and established scientists; and 3) Between
dermatology specialists and those from other departments/fields. Participation of young scientists is strongly
encouraged by presentation opportunities and competitive travel awards. The central support of this meeting is
a multi-year conference grant from the NIH that allows advance planning of program themes by leading Program
Chairs and invitation of highly competitive speakers. Annual fundraising from corporate and foundation sources,
together with modest registration fees, offset the balance of meeting production costs. The Symposium
communicates its findings to the broader academic community through annual publication of proffered, peer
reviewed papers in the Journal of Investigative Dermatology with waiver of submission fees under the Montagna
Symposium on the Biology of Skin logo. Topics planned and discussed in this proposal include the 70th
anniversary meeting “Visualizing the Future of Skin Biology and Dermatology”, “Skin of Color Dermatology: The
Interaction of Science and Society”, “Precision Dermatology”, “Resident Memory T Cells in Human Health and
Disease”, and “Innovative Technologies to Visualize and Diagnose the Skin”. We are thrilled to return to in-
person meetings following the disruptive COVID-19 pandemic and have renewed and increased our commitment
to gathering diverse researchers to elevate the meeting's discussions. This meeting uniquely fulfills the NIH goal
to advance scientific progress in understanding of the basic structure and molecular regulation of human biology
and disease and meeting themes have reflected and helped shape NIAMS' goals and mission.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The Montagna Symposium on the Biology of Skin is a conference that has existed for nearly 70 years and creates a unique forum for researchers and physicians to discuss the latest scientific progress on aspects of skin biology that inform about the causes of skin disease. This conference brings together a diverse mix of health professionals and researchers from different fields whose multi-disciplinary interactions are needed to strategize and take action to develop new treatments for diseases involving skin. Over time, many breakthroughs in skin research discussed at the Montagna Symposium have shaped whole fields in science and medicine and the Symposium has also been a key career development step for young researchers and clinicians-in-training to meet and learn from renowned scientific leaders.